Single Molecule Imaging of RIM1 Scaffold in Photoreceptor Neurotransmission

Project 002 (079): Single Molecule Imaging of RIM1 Scaffold in Photoreceptor Neurotransmission, Choi PL
PROJECT SUMMARY/ABSTRACT
Photoreceptors in the retina transmit a response to light across their synapses by regulating the release
of glutamate-containing synaptic vesicles at the active zone. The photoreceptor synapse uses a ribbon-type
active zone composed of multi-domain scaffold proteins to promote fast and continuous neurotransmitter release
that is needed for normal vision. Dysregulation of the scaffold proteins involved in synaptic transmission is
associated with retinal diseases leading to blindness. However, we have limited knowledge of the molecular
mechanisms underlying these pathologies, which is critical for understanding and treating these diseases. Our
long-term goal is to determine the molecular mechanisms of synaptic vesicle release at the active zone and
how the cellular machinery is dysregulated in retinal disease leading to visual disabilities. The overall objective
of this application is to determine how an autosomal dominant mutation in Rab3-interacting molecule 1 (RIM1)
causes the blinding disease, cone-rod dystrophy type 7 (CORD7). Our central hypothesis for this proposal is
that the structural dynamics of RIM1 regulates the scaffolding activity, which is disrupted by the CORD7 disease
mutation (Aim 1), leading to impairment of a functional active zone by altering phase separation and vesicle
fusion (Aim 2).
RIM1 is the central component regulating the function of the active zone by directly or indirectly interacting
with all other active zone proteins. RIM1 consists of tandem arrays of highly structured domains connected by
intrinsically disordered linkers, which precludes structural analysis by traditional methods. To overcome this
limitation, we will use the state-of-the-art single-molecule fluorescence resonance energy transfer (smFRET) to
determine the dynamic structure of RIM1. We have established an in vitro reconstituted system recapitulating
the synaptic geometry of the active zone, allowing protein dynamics and function to be observed in a biologically
relevant context. Our novel assay will provide the first structural details of RIM1 and how the CORD7 mutation
affects the function of RIM1 by altering the scaffolding activity.
How the cellular machineries are organized to allow the release of synaptic vesicles is incompletely
understood. RIM1 undergoes liquid-liquid phase separation (LLPS), condensing into a membrane-less
“organelle”, when mixed with other active zone proteins. This scaffold organization suggests that LLPS is
essential for vesicle release at the active zone. To determine the functional significance of RIM1 LLPS in vesicle
fusion, we will conduct a novel single-vesicle fusion assay that we developed. These approaches will provide
the first structural details of RIM1 during LLPS and how LLPS drives vesicle fusion. Achieving single-molecule
resolution of protein dynamics and its function in a biological context related to blindness will uncover novel
mechanisms of RIM1 that are hidden in ensemble measurements, and set a platform for molecular analysis of
disease mutations such as CORD7.